GP130 Antagonism in Porcine RV Pressure Overload

Project Summary
Pulmonary arterial hypertension (PAH) is a lethal disease with a median survival of only 5-7 years.
Pathophysiologically, PAH is a progressive vasculopathy of the precapillary pulmonary vessels that increases
pulmonary arterial pressures and pulmonary vascular resistance while reducing pulmonary arterial compliance.
The changes in the pulmonary vasculature augment the work load of the right ventricle, which ultimately results
in right ventricular dysfunction (RVD). The presence of RVD is the greatest risk factor for death in PAH;
however, no current PAH therapies actually target the RV directly. In this proposal, we will investigate the
hypothesis that GP130 activation in RV cardiomyocytes promotes cardiomyocyte dysfunction via microtubule
remodeling which causes t-tubule derangements and mitochondrial metabolic dysfunction. We will use state-
of-the-art approaches to probe the molecular and physiological effects of GP130 antagonism on right
ventricular function in porcine RV failure.

Public health relevance
Project Narrative Using relevant translational approaches we will dissect how GP130 signaling modulates right ventricular function via microtubules in preclinical pulmonary arterial hypertension (PAH). Our findings will have broad implications for future treatment of PAH, a lethal disease with a median survival of only five to seven years. No current therapy targets the right ventricle directly; thus there is a critical need to define targetable molecular mechanisms that cause right ventricle disease so as to develop an effective therapy.